Engaging Multidisciplinary Health System Stakeholders to Create a Process for Implementing Machine-Learning Enabled Clinical Decision Support

PROJECT SUMMARY/ABSTRACT
The proliferation of “black box” Machine Learning (ML) models for Clinical Decision Support (CDS) has raised
concerns regarding CDS interpretability, actionability and overall usability, rendering a critical need for a clear
process that engages various stakeholders including both developers and users in implementation planning.
Our long-term goal is to formalize a process to guide health systems in planning, monitoring and evaluating
CDS implementation. The overall objective for this R21 is to develop and evaluate a generalizable strategy
to bring multidisciplinary stakeholders together during the CDS exploration phase to identify
facilitators and barriers to implementation in their contexts. In doing so, we will use Participatory System
Dynamics (PSD) modeling as a multi-component strategy to evaluate and plan implementation with
stakeholders during the exploration phase of implementation, when decision-making occurs, in a way where
ML-enabled CDS can be sustained over time. As such, we will focus on the upstream implementation
outcomes of acceptability, appropriateness, and feasibility of ML-enabled CDS. The rationale for this project is
that a process that engages diverse stakeholders in implementation planning early on will clarify commitment
to implementation and potential for adoption by revealing acceptability, feasibility, and appropriateness. For
this project we will focus on one particular set of ML-enabled CDS: Early Warning Scores (EWSs), used to
identify decompensating patients. We plan to accomplish our overall objective by pursuing two specific aims: 1.
Engage multidisciplinary stakeholders involved in EWS implementation (users, developers, implementers,
owners) from two systematically varying adoption contexts to co-define common barriers and facilitators to key
implementation outcomes of CDS acceptability, appropriateness, and feasibility using group model building
scripts from the field of system dynamics and 2. Evaluate the PSD process by measuring change in
commitment to adopt CDS (using measures of acceptability, appropriateness, and feasibility), eliciting
feedback, and estimating intervention effort. We will obtain data via a series of group modeling sessions from
stakeholders who have used CDS in different contexts, where alerts vary by target user, time, and frequency
among other factors. We will employ well-defined scripts from the field of System Dynamics modeling to
facilitate group discussion toward developing a shared theory about the problem of ML-enabled CDS response
(Aim 1). Because implementation of any strategy requires adaptation, we will evaluate the PSD process (Aim
2) to refine and prepare for use elsewhere. This contribution is significant because EWSs are widely used
across both academic and community hospitals. This contribution is innovative by using group modeling
techniques for the problem of ML-enabled CDS implementation, creating both methodological and substantive
findings. A future R01 will prospectively assess benefits of using this process in multiple use case settings
while continuing to build out the dynamic systems model of factors for downstream adoption.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will contribute an evidence-based process generalizable to other settings to guide successful implementation and uptake of clinical decision support. The process developed from this R21 will help to advance NLM’s goal of optimizing use of bioinformatics tools that apply large, complex data sets to augment clinical decision making. Our new and substantially different approach to evaluating implementation of ML-enabled CDS will actively involve both developers and end users in discussions that will help to align diverse perspectives, opening new horizons for an implementation planning strategy accepted by diverse stakeholders to improve uptake across clinical settings.